Core--Chemical genetics and targeted genomics approaches to Parkinson's disease

The aim of this core is to provide personnel to utilize modern techniques in gene expression arrays, protein expression analysis, and high-throughput screening to support reseaarch in projects 1-3. One individual will be primarily engaged in gene expression studies, providing a detailed comparison between tissue from patients with Lewy body-associated diseases; DLBD, PD, and MSA and transgenic animals (project 3) and cell culture models (project 2). A second individual will be utilized to convert the assays developed in conjunction with projects l and 2 into assay suitable for high-throughput screens. This individual will subsequently screen selected small-molecule libraries to find molecules that alter these processes. These molecules will be used as tools to test models pathogenesis.